Trauma and Inflammation Research Training

Project Summary
This is a competitive renewal application for the post-doctoral multidisciplinary basic science Trauma and
Inflammation Research Training Program at the Department of Surgery, The Alpert Medical School of Brown
University. The Program's goal is to identify, recruit, and train the next generation of Trauma and Inflammation
Scientists with particular emphasis on retaining MDs in academic careers. Formal training in research involves
the acquisition of the technical, intellectual, philosophical and ethical habits and abilities of the scientist.
Development of these traits in the trainees is the most important goal of the Program. Faculty from the
Departments of Surgery (Acute Care, Burns, Cardiothoracic, Trauma); Medicine (Infectious Diseases,
Pulmonology); Orthopedics; Molecular Microbiology and Immunology; Molecular Biology, Cell Biology and
Biochemistry; Molecular Pharmacology, Physiology, and Biotechnology; and Pathology at Brown University, and
their respective laboratories, afford trainees ideal opportunities to select areas for research. The Level 1 Trauma
and Burn Centers at Rhode Island Hospital provide clinical correlates for basic research. The Program is led by
a Director who is advised and assisted by an Executive Committee in the selection, guidance and evaluation of
trainees. A Co-Director assists the Director in the day-to-day running of the program and stands-in in his
absence. An Extramural Advisors Panel assures the excellence of the Training Program. Two trainees per year
are selected nationally, among residents in any branch of surgery or medicine and recently graduated PhDs.
Major emphasis is placed on recruiting candidates from under-represented minorities, the disabled, and
veterans. The Training Program lasts two years. The curriculum includes required courses in Biostatistics,
Responsible Conduct of Research, Rigor and Reproducibility, and Scientific Writing, as well as elective courses
tailored to the specific needs of the trainees. A faculty mentor and an Advisory Group (modeled after a PhD
thesis committee and including an experienced trauma care clinician) provide direction, support and supervision
to the trainee, as well as assuring the clinical relevance of the research project. The Advisory Group assists the
trainee and his/her mentor in designing and implementing an Individual Development Plan (IDP) to guide the
trainee’s scientific development. Trainees will have no mandatory clinical responsibilities during the training
period. This comprehensive program provides the trainee with the technical and intellectual tools necessary to
pursue an academic career in research areas related to trauma and inflammation.

Public health relevance
Project Narrative Trauma continues to be a leading cause of death and disability in the USA. The Program aims to train surgical residents or recently graduated PhDs as the next generation of Trauma Scientists, capable of bringing advances in the understanding of the underlying mechanisms of “trauma disease” and inflammation to the bedside and improve the outcome of trauma victims.